Glomerular and Tubular Function in the Diabetic Kidney

DESCRIPTION (provided by applicant): Over the past decade, we have developed a tubular hypothesis of glomerular filtration to account for several nuances of kidney function in early diabetes. The theory was first applied to diabetic hyperfiltration and we have demonstrated that the overriding stimulus comes from the proximal tubule where an early increase in reabsorption leads to a rise in single nephron GFR (SNGFR) through the normal physiologic actions of tubuloglomerular feedback (TGF). Another feature of the proximal tubule in early diabetes is that it assumes increased responsibility for salt balance. This salt sensitivity of the proximal tubule is responsible for the so-called salt paradox in early diabetes where changes in proximal reabsorption encounter an intact TGF system leading to a reciprocal effect of dietary salt on GFR. What confers heightened salt-sensitivity on the diabetic proximal tubule is unknown, although hypertrophy, per se, seems to be involved. The focus of this research will continue to be on events that befall the kidney early in diabetes, long before injury develops. We aim to better understand the molecular mechanisms involved in proximal hyperreabsorption, glomerular hyperfiltration and kidney growth in the early diabetic kidney with the assumption that early diabetes-induced changes are important for the long-term outcome. During hyperglycemia, the kidney may sense hyperglycemia via tubular glucose uptake and a high fraction of overall proximal tubular reabsorption is linked, directly or indirectly, to sodium-glucose co-transport via SGLT1 andSGLT2. This prompted us to consider in, Specific Aim 1, the role of these SGLTs as controllers of proximal reabsorption, glomerular filtration, and kidney hypertrophy in early diabetes and as effectors of progression in a standard mouse model of diabetic nephropathy. The core methodology will continue to be renal clearance and micropuncture in the rat and mouse, including gene-targeted mice lacking SGLT1 and SGLT2,which we have in hand. A more novel effector of proximal reabsorption is the incretin, glucagon-like peptide 1(GLP-1), which has outstanding potential as a proximal diuretic. GLP-1 is degraded by the depeptidyl peptidase 4(DPP-4), which is co-expressed with the GLP-1 receptor in proximal tubular brush border. Both GLP-1 and DPP-4activity are altered in diabetes. Specific Aim 2 is designed to understand the role of the GLP-1 / GLP-1 receptor system and DPP-4 as determinants of proximal reabsorption and glomerular filtration. Studies will employ clearance and micropuncture in the pharmacologically manipulated rats , genetically manipulated mice lacking the GLP-1 receptor, and wild type transplanted with GLP-1 receptor null kidneys. In addition we will use specific pharmacological tools to perturb this system, including DPP-4 inhibitors and GLP-1 agonists, which are currently used to augment insulin secretion in patients with type 2 diabetes. Specific Aim 3 is to determine impacts of renal SGLT and incretin signaling beyond the kidney, namely on blood pressure and salt balance.

Public health relevance
PUBLIC HEALTH RELEVANCE: Diabetes affects the kidney in stages. At the very onset of diabetes, the kidney grows large and GFR becomes supranormal. Recent basic and clinical research on the diabetic kidney is weighted toward sclerosis and kidney failure that occur many years later. The contemporary management of patients with diabetes is aimed toward slowing the progression to kidney failure after the onset of proteinuria and sclerosis. To prevent diabetic nephropathy altogether would be preferable, but to accomplish this we first need to understand earlier events that antedate renal injury. There is a longstanding idea that the early hemodynamic phenotype provokes the subsequent demise of a diabetic kidney. This research focuses on that early stage of diabetes, before there is injury or sclerosis. Project Narrative Diabetes affects the kidney in stages. At the very onset of diabetes, the kidney grows large and GFR becomes supranormal. Recent basic and clinical research on the diabetic kidney is weighted toward sclerosis and kidney failure that occur many years later. The contemporary management of patients with diabetes is aimed toward slowing the progression to kidney failure after the onset of proteinuria and sclerosis. To prevent diabetic nephropathy altogether would be preferable, but to accomplish this we first need to understand earlier events that antedate renal injury. There is a longstanding idea that the early hemodynamic phenotype provokes the subsequent demise of a diabetic kidney. This research focuses on that early stage of diabetes, before there is injury or sclerosis. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Overthepastdecade, wehavedevelopedatubularhypothesisofglomerularfiltrationto account for several nuances of kidney function in early diabetes. The theory was first applied to diabetic hyperfiltration, asfollows: Whileacceptingthatmanyfactorscouldcontributetodiabetichyperfiltration,wehavediscoveredthat the overriding stimulus usually comes from the proximal tubule where an early increase in reabsorption leads to ariseinsinglenephronGFR(SNGFR)throughthenormalphysiologicactionsoftubuloglomerularfeedback(TGF) (reviewed in {60b;69}). Another feature of the proximal tubule in early diabetes is that it assumes increased responsibility for salt balance, which leads to a paradoxical effect of dietary salt on GFR when high salt diet causes a precipitous decline in proximal reabsorption leading to activation of TGF {67}. This salt paradox proves the principle that one can mitigate hyperfiltration through physiologic maneuvers to reduce growth and hyperreabsorption in the proximal tubule. During hyperglycemia, a high fraction of proximal reabsorption is linked to sodium-glucose co-transport (SGLT). This prompts us to consider the role of SGLT1 and 2 in diabetic hyperfiltration. A more novel effector of proximal reabsorption is a system made up of the incretin, glucagon-like peptide1(GLP-1),theGLP-1receptor(GLP-1R),andthedipeptidylpeptidase-4(DPP-4),whichinactivatesGLP-1. GLP-1 has outstanding potential as a proximal diuretic and renal vasodilator (Preliminary Data). Also, various components of this system are subject to dietary manipulation or are affected by diabetes in ways that might contribute to, or confound, hyperfiltration. The Specific Aims of this competing continuation are based on old | observationsandpreliminarydata regardingSGLTandincretins. Wewilldelveslightlyintodiabeticnephropathy, | but will continue to focus mostly on events that befall the kidney early in diabetes, long before injury develops. | The core methodology will continue to be renal micropuncture in the rat and knockout mouse but we will also go | beyond the kidney to examine the impact of intrarenal processes on blood pressure and salt balance. | Aim 1: Explain the influence of sodium-glucose co-transporters (SGLT1 & 2) on kidney function | andstructureinearlyandlatediabetes.Inourexperience,maneuversthatsuppressdiabetichyperfiltration | tend to act first on the tubule to activate TGF. Since SGLT2 accounts for considerable proximal reabsorption in | diabetes,weexpectedhyperfiltrationtodependstronglyonSGLT2. However,preliminarydatarevealonlyasubtle | tendency for pharmacological blockade or genetic deletion of SGLT2 to lower GFR in early diabetes. Aim 1A is | to learn whether SGLT1, which is expressed downstream of SGLT2 and will see more glucose in diabetes, bears | a signal that leads to kidney growth and hyperfiltration in early diabetes. In Aim 1B, we will employ different | inhibitors of proximal reabsorption to examine the possibility that the less-than-expected impact of SGLT2 | blockade on diabetic hyperfiltration occurs because the macula densa is influenced by particular constituents of | the tubular fluid to hold GFR down under some circumstances and allow it to rise under others. This is easy to | imaginebecause little is known about how the macula densa processes long-term changes in distal delivery. Aim | 1C, which was added in response to the prior review, is to determine whether hereditary lack of SGLT1 or SGLT2 | affects the course of diabetic nephropathy in a preferred mouse model of that disease. Aim2:Examinethemechanism(s)wherebytheincretinsystemaffectsproximalreabsorptionand, glomerularfiltrationinnormalphysiologyandinearlydiabetes.Aim 2A istocharacterizetheinfluence of DPP-4 over GFR and proximal reabsorption. Aim 2B is to do the same for GLP-1. To accomplish this, we will use pharmacological tools and mice lacking the GLP-1 receptor. We will attempt to explain why the body uses GLP-1,whichrespondstodietaryfatandcarbohydrate,tosuppressproximaltubularreabsorption.Wewillexplore how renal activity of the system is modulated by diets variously rich in fat, carbohydrate, or protein. We will | examine whether insulin is a secretagogue for GLP-1 that acts on the kidney. Denervation and kidney | transplantation studies have been added in response to the prior review to address the possibility that systemic | GLP-1 signaling arrives at the kidney by way of the renal nerves or another circulating hormone. In Aim 2C we will explore the possibility that impaired incretin signaling contributes to proximal tubular hyperreabsorption, glomerular hyperfiltration, kidney growth, or the salt paradox in early diabetes. | Aim 3: SGLT and incretin signaling as determinants of salt and blood pressure homeostasis in | normal physiology and in early diabetes. This aim is to determine impacts of renal SGLT and incretin | signaling beyond the kidney, namely on blood pressure and salt balance. Phenomenologically, salt balance is a | linear dissipative process with a single rate constant {73}, which is the same for blood pressure and salt balance. | It can be derived from parameters of nephron function or it can be measured in salt-balance or blood pressure | experiments. We plan to use salt balance and blood pressure telemetry data after a step change in salt intake to | measure the effects of manipulating SGLT and incretins on this rate constant. At the same time, we will learn | whether diabetes increases salt sensitivity of blood pressure through changes in SGLT and/or incretin signaling. | Comparing effects onthemeasured rate constant vs effects predicted by micropuncture will provide a reality test.